Targeting Biomechanical Signaling in AAA

Abdominal aortic aneurysms (AAA) afflict ~8% of Americans and ruptured AAA carries >80% mortality.
Screening programs have increased identification of small AAA, but there is no directed medical therapy to inhibit
growth and rupture rates have not decreased. The technologic advances in endovascular AAA repair have been
vast while our ability to correlate pathology to clinical care has lagged. There is a clear need for a platform to
incorporate patient-specific mechanobiologic stressors to complement aortic diameter measurements and inform
treatment decisions. Inhibition of two mechanical signaling molecules, the AngiotensinII-type 1 receptor (AT1R)
and the serum and glucocorticoid inducible kinase-1 (SGK-1), has been explored in pre-clinical experimentation
and hold promise for clinical application. In mice treated with the AT1R blocker Losartan or SGK-1 inhibitor
EMD638683, AAA growth was abrogated and only ~25% aortic dilation was observed, suggesting that there was
a non-mechanical contribution to this early matrix remodeling. Additionally, since both inhibitors led to the same
degree of aortic remodeling, it has raised the question of whether AT1R and SGK-1 operate interdependent
mechanical signaling cascades. Interest in SGK-1 as a druggable target in small AAA was amplified when it was
discovered that upregulated SGK-1 activity promoted VSMC pro-inflammatory cytokine synthesis, while SGK-1
inhibition restored VSMC contractile function as quantified by ultrasound-derived pulse propagation velocity
(PPV). Therefore, SGK-1 is a prime candidate to transduce aortic mechanical strain to promote VSMC synthetic
activity in AAA growth. We propose that VSMC synthetic phenotypes evolve during AAA growth based on
mechanical activation of SGK-1 and that the plasma levels of well-documented AAA biomarkers represent an
opportunity to define these transitions. Specific biomarkers assessed in this project incorporate inflammatory
cytokines (Interleukin-6, IL-6), protease systems (Matrix metalloproteinse-9, MMP-9; CathepsinS, CtsS;
CystatinC, CysC), markers of calcification (Osteoprotegerin, OPG), and fibrillar matrix peptides (TenascinC,
TNC). Integrating these pathologic matrix markers (PMMs) with ultrasound-derived mechanical aortic strain and
immunohistochemical analysis may enable prediction of aortic wall instability. We hypothesize that increased
aortic stiffness can mechanically activate SGK-1 to alter VSMC synthetic activity to promote PMM production,
aortic matrilysis, and AAA growth. In Aim 1, stimulation with axial tension will confirm upregulated SGK-1 activity
in murine abdominal aortic rings. Dependence of PMM expression on SGK-1 activity will be explored by blocking
with EMD638683 versus Losartan. Data will be computationally integrated to explore additional pathways
engaged in tension-induced VSMC synthetic activity. In Aim 2, mice will undergo AAA induction with peri-
adventitial application of CaCl2. Ultrasound-derived aortic strain parameters include quantification of global radial
strain, distensibility, and pulse propagation velocity. Assessment of aortic strain parameters, plasma PMMs, and
SGK-1 activity will occur at days 0, 7, 21, and 42. Integrity of matrix components as well as the quantification
and localization of inflammatory infiltrate and VSMC phenotypes will be completed utilizing the Hyperion Imaging
Mass Cytometry. To demonstrate the integral role of SGK-1 in PMM production, aortic wall inflammation, and
VSMC synthetic phenotype, a subset of animals will have EMD638683 versus Losartan therapy initiated at day
21. Computational modeling will integrate aortic strain parameters, PMMs, and SGK-1 activity to define
synergistic relationships that can be further interrogated. In Aim 3, patients with normal aorta versus small AAA
will have plasma PMMs and ultrasound-derived aortic strain collected annually over 3 years. Computational
assessment of this data will further support the concept that these easily accessible biomechanical indicators
can be utilized to predict aortic growth. Integrating mechanical stressors with PMMs may enhance the analysis
of aortic wall pathobiology during growth of small AAA to expedite identification of druggable targets and the
characteristics of patients who would benefit from that therapy.

Public health relevance
Abdominal aortic aneurysms (AAA) afflict ~8% of Americans and ruptured AAA carries >80% mortality. AAA screening programs have increased identification of small AAA, but there is no medical therapy to attenuate dilation and rupture rates have not decreased. Thus, the treatment paradigm of annual surveillance of growth toward the surgical threshold has not been revised in over 20 years. In retrospect, clinical trials of medical therapy for AAA may have failed to show an effect on rate of growth due to the broad inclusion criteria. We propose that easily accessible, minimally invasive techniques may be engaged to gather biomechanical data of small AAA to improve characterization of this pathology. More specifically, aortic strain and plasma pathologic matrix markers may reflect the evolving aortic wall remodeling. Using computational analysis of acquired biomechanical data, this project will establish a model to define AAA biology that will be responsive to medical therapy, thereby shifting the current surgical treatment paradigm.